STUDY OF NUTROPIN IN TREATMENT OF GROWTH HORMONE DEFICIENT ADULTS

Nutropin (somatropin for injection) in adults with acquired growth hormone deficiency will reduce the amount of body fat, increase muscle strength and endurance, and improve the quality of life.